NEUROTENSIN AND METHAMPHETAMINE EFFECTS

DESCRIPTION (provided by applicant): The incidence of methamphetamine (METH) abuse is alarmingly high, and METH abuse and addiction remains a critical societal problem due in part to its disturbing consequent effects such as violent behavior and psychosis. Thus, elucidating the basis of such dangerous behaviors and developing strategies to manage these adverse consequences is important. Of particular interest to our lab are the effects of METH-induced increases in extracellular dopamine (DA) on the functioning of striatal efferent pathways such as the striatonigral projection. During the past funding period we observed that DA release induced by a high dose of METH did not appear to activate the striatonigral pathway as previously thought. Although a high dose of METH increased tissue levels of the neuropeptides associated with the striatonigral pathway (substance P [SP] and neurotensin [NT]) and increased expression of their precursor mRNAs, it surprisingly did not increase extracellular levels of the neuropeptides in the terminal fields of these nigral projections. Conversely, the low dose of METH tended to decrease tissue levels of SP and NT, did not alter expression of the precursor mRNAs, and significantly elevated the extracellular levels of the neuropeptides in the terminal fields. These data therefore lead to the hypothesis that the functional output of the striatonigral pathway is increased by low doses of METH and unaffected by administration of high doses of METH. This hypothesis will be tested by accomplishing the following Specific Aims: A) Establishing the effect of low and high doses of METH on the functional output of the striatonigral pathway. B) Resolving the mechanism underlying the differential effect of low and high doses of METH on the activity of the striatonigral pathway. C) Determining the behavioral consequences of the differential effects of low and high doses of METH on the striatonigral pathway. Elucidating the impact of low vs. high doses of METH on the striatonigral projection will be critical for determining the mechanisms responsible for the differential dose-dependent effects of METH and for improving therapeutics for METH-related problems, as well as for other basal ganglia-related disorders.